METABOLIC ALDEHYDES AS IMMUNE EFFECTORS AGAINST TUBERCULOSIS

This proposal will continue to test the hypothesis that host-derived aldehydes are a critical component of host
immunity against Mycobacterium tuberculosis. In the past funding period, we used bacterial and mouse
genetics, biochemistry, immunology and cell biology experiments to test this hypothesis. We have identified
bacterial mutants that are more sensitive than parental strains to various aldehydes. We have shown that
these mutants are attenuated in mice with defects in aldehyde detoxification, showing that host-derived
aldehydes can contribute to bacterial control. We continue to characterize the bacterial and host pathways. We
are now working with TB Alliance to test frontline TB drugs on mice defective for aldehyde detoxification to
determine if repurposing an FDA-approved drug that inhibits ALDH2 could improve TB treatment.

Public health relevance
The mechanisms used by the immune system to control bacterial infections are incompletely understood. We propose that metabolic intermediates, namely aldehydes, are used by the immune system to kill Mycobacterium tuberculosis and possibly other microbial agents. This proposal will identify sources of metabolic aldehydes that can control microbial growth as well as bacterial pathways that provide resistance to aldehydes.